Basic Training at the Intersection of Innate and Adaptive Immunity in Disease

Project Summary/Abstract
This renewal application builds on the strength of our world class Immunology faculty for scientific training at the
interface of innate and adaptive immunity to continue our Immunology training program. We request support
each year for five students in our predoctoral training program as well as two postdoctoral trainees. This training
program is based in the Department of Immunology at the University of Washington, with Drs. Michael Gale, Jr.
and Joan Goverman serving as multi-Principal Investigators and Program Co-Directors. Our training faculty
include specialists in immune system development, infectious disease immunology, autoimmunity,
allergy, cancer immunology, immunodeficiencies, innate immunity, vaccinology, and immunotherapeutics.
Our program features predoctoral student training that combines research, coursework, and scientific
learning in a rigorous training program to teach our students critical thinking, scientific approach, effective
communication, and science ethics. Our new postdoctoral training program is designed to encompass a
focus on research excellence, career exploration, teaching, training in grant writing and ethics, mentoring
skills, and leadership. Predoctoral trainees are selected from our own Immunology graduate program, the
University of Washington Molecular and Cellular Biology graduate program, and from the Medical Scientist
Training Program; postdoctoral trainees will be selected from applicants within the labs of our training
faculty. Training takes place at the University of Washington and our partner institutions including the
Benaroya Research Institute, the Center for Infectious Disease Research, the Fred Hutchinson Cancer
Research Center, Seattle Children's Research Institute and the Institute for Systems Biology. Our
trainees benefit from the rich, diverse, and interactive Immunology community at the University of
Washington and our partner institutions. We provide trainees the opportunity to attend specific national
meetings annually, exposure to different career paths, formal evaluation of trainees' scientific presentations
and progress by a committee composed of members of our training faculty, and dedicated interactions with
selected Immunology seminar speakers. An External Advisory Committee provides ongoing evaluation of
the training program.

Public health relevance
Project Narrative This application is to seek renewal and expansion of our T32 training program in Immunology to include support of five predoctoral positions and two postdoctoral positions. Our overall goal is to train the next generation of scientists to apply immunological knowledge for improvement of human health.